A Safe, Fast, and Cost-Effective System for Tissue Removal in Laparoscopic Hysterectomy and Other Minimally Invasive Surgery

Abstract
In the United States approximately 500,000 hysterectomies are performed per year, typically for uterine
enlargement as a result of fibroids. In 2014 the FDA provided guidance against uncontained laparoscopic power
morcellation, a method of rapidly removing a large specimen (such as the uterus) during minimally invasive
surgery. The FDA determined that power morcellators increased risk of cancer spread in women undergoing
laparoscopic gynecologic surgery for presumed benign fibroids. Preventing the spread of hidden cancers during
minimally invasive surgery is an unaddressed need across many procedures, including: hysterectomy,
myomectomy, colectomy, oophorectomy, splenectomy, and nephrectomy. The FDA guidance left gynecologic
surgeons without great tools for removing large uteri minimally invasively. The primary technique developed in
response to the guidance, called contained manual morcellation, is an off-label technique which requires putting
the uterus in a container and extracting it with a scalpel and graspers through an incision in the abdomen or out
the vagina. The technique is slow (often requires 10-30 scalpel blades and takes 20-40 minutes), and ineffective
at containing cancer cells (8-41% documented container breaches). Another alternative, open surgery, is costly
(~2.75 nights in the hospital) and has high associated morbidity / mortality (1:5000 mortality, 1:20 serious
complications).
Claria Medical is developing a Tissue Containment and Extraction System (TCES) which will enable the safe,
rapid and cost-effective removal of large uteri minimally invasively. The improved surgical speed and safety that
the Claria TCES provides enables surgeries to be performed in a same-day outpatient format avoiding open
surgery, complications, and long hospital stays. The key milestone of this Phase II proposal is to submit the
TCES to the FDA for 510(k) clearance. Aim 1 focuses on design optimization and execution of several design
verification and validation protocols including: biological barrier testing, electrical safety testing, biocompatibility
testing, sterilization and shelf life testing as required by the FDA. Aim 2 is a formative usability study with four
surgeons and develops a surgical training protocol and validation program with surgical simulators and an animal
model. Aim 3 is a summative evaluation with 34 surgeons validating the training protocol and usability of the
Claria TCES during unassisted simulated uterine extraction surgery. Subsequent to FDA 510(k) clearance, ~1.5-
2 years after funding of this proposal, Claria will perform an additional post-market clinical evaluation, a
commercial launch, and clinical studies in additional indications for benign and malignant tissue removal.

Public health relevance
Narrative Minimally invasive hysterectomies which require benign tissue reduction and removal are estimated at over 350,000 per year in the United States. Current methods have several pain points: Higher complication rates, higher cost, and reduced speed. We propose a safe, rapid, easy to use, and cost-effective tissue removal system that can aid in hysterectomy and other minimally invasive surgeries which require tissue reduction.